Minimizing Hypoglycemia in Adults with Type 1 Diabetes through an Integrated Mobile Health and Continuous Glucose Monitoring System

Project Summary / Abstract
Level 2 hypoglycemia (blood glucose <54 mg/dL) is a medical emergency that can lead to confusion, cardiac
arrhythmias, and even death. This dangerous condition occurs frequently in patients with type 1 diabetes
(T1D), including those using continuous glucose monitoring systems (CGMs). In prior studies of patients not
using CGMs, researchers identified patient beliefs that interfere with hypoglycemia treatment. However,
treatment interfering beliefs in CGM users remain to be evaluated, and an intervention to impactfully address
these beliefs among CGM users is needed. The goal of this project is to comprehensively evaluate beliefs that
interfere with hypoglycemia treatment in adult T1D CGM users, and to develop a novel behavioral intervention
program to address these beliefs and minimize hypoglycemia. Mixed methods techniques can guide
identification of hypoglycemia treatment interfering beliefs, and determine those predictive of level 2
hypoglycemia for targeted intervention development. Mobile health (mHealth) technology can be linked to
CGM data to develop widely accessible, patient-centered, real-time interventions to address treatment
interfering beliefs. Central hypothesis: An mHealth-CGM behavioral intervention program can mitigate beliefs
that interfere with hypoglycemia treatment and reduce hypoglycemia in T1D CGM users. Aims: (1) Acquire an
in-depth understanding of CGM users’ beliefs that interfere with hypoglycemia treatment; (2) Develop
an mHealth text messaging program that generates automated, real-time behavioral interventions to mitigate
beliefs that interfere with hypoglycemia treatment; (3) Assess the feasibility, acceptability and preliminary
efficacy of the mHealth-CGM behavioral intervention program in reducing hypoglycemia in a pilot behavioral
clinical trial. Candidate: Yu Kuei Lin, MD is an endocrinologist and early career investigator with the career
goal of becoming an independent investigator, identifying and developing interventions to mitigate barriers to
hypoglycemia management and prevention in diabetes patients. He has a successful history of designing and
conducting hypoglycemia survey studies and biomedical clinical trials, but needs more training in advanced
behavioral science research. This K-23 award will provide him with unique skills necessary to identify barriers
to managing or preventing hypoglycemia, and to develop and evaluate patient-centered, targeted intervention
programs delivered through mHealth aimed at optimizing hypoglycemia management and prevention. Training
Objectives: (1) Acquire skills in conducting qualitative and mixed methods research; (2) Gain skills in
developing mHealth behavioral interventions; (3) Develop expertise in conducting behavioral clinical trials. Dr.
Lin’s training will be supported by highly experienced, complementary mentors and advisors, advanced
didactic coursework, and participation in research and career development seminars and meetings within a
resourceful, enriching training environment. An NIDDK K-23 award will provide Dr. Lin the protected time and
training needed to help all patients with diabetes minimize hypoglycemia and improve health outcomes.

Public health relevance
Project Narrative About 1.6 million people in the U.S. have type 1 diabetes, who face the daily threat of developing dangerously low blood glucose episodes, potentially resulting in confusion, life-threatening cardiac events, or even death. Despite using advanced diabetes technologies such as continuous glucose monitors, many patients continue to develop these devastating episodes due to sub-optimal management of low blood glucose events. This research project will expand knowledge of type 1 diabetes patients’ beliefs that prevent them from treating low blood glucose episodes; resultant insight will be applied to develop and pilot test a patient-centered behavior- changing program to improve patients’ self-management of low blood glucose episodes.